Biomedical Information Technology, Software Development, and Informatics Support

Cures funding in support of: The purpose of this Statement of Work (SOW) is to acquire professional Biomedical Consultation and Information Technology, Software Development, and Informatics Support (BITSDIS) services for the National Cancer Institute (NCI) Center for Biomedical Informatics and Information Technology (CBIIT).